Mechanisms of Eukaryotic Gene Regulation

Project Summary/Abstract
The major long-term objective of this research program is to understand the mechanisms of regulation of RNA
polymerase II transcription in animals. Why is it important to study gene expression? The basis of a diverse
range of biological phenomena, including many human diseases, can be traced to the proper or improper
expression of a gene or set of genes. Thus, new insights into the mechanisms of gene expression will have a
far-reaching impact upon the biological sciences. Specific emphasis will be placed upon the study of the RNA
polymerase II core promoter, which is the short stretch of DNA that directs the initiation of transcription. Why is
it important to study the core promoter? First, the core promoter is the "gateway to transcription" – the site of
convergence of the signals that lead to transcription initiation. In this regard, the core promoter is at a key
strategic position in the transcription process. Second, the core promoter is a central and integral component
of the RNA polymerase II transcription system that comprises the signals in the chromatin (including DNA
sequence motifs) and the factors that read those signals and carry out the transcription process. At present,
core promoter elements are best understood in organisms other than humans. The human core promoter,
which is complex and difficult to decipher, is the next challenge. Hence, future goals include the elucidation of
the components of the human core promoter and the identification and analysis of the transcription factors that
function with specific sequence elements to mediate the regulation of gene expression in humans. This work
should provide new and important insights into the mechanisms of transcriptional regulation in humans. A
second objective of this research program is to understand the diverse functions of chromatin – the natural
form of DNA in the eukaryotic nucleus. Because DNA is the genetic material and is thus of the utmost
importance, there is a strong and broad interest in the factors and mechanisms that affect chromatin and DNA
structure and integrity. In particular, these processes will be investigated at the interface of chromatin and
DNA – that is, in the context of chromatin rather than with DNA alone. One particular area of interest is the
study of factors that protect DNA from damage by binding to nucleosomes. New insights into the protection of
DNA against damaging agents such as reactive oxygen species would not only provide important fundamental
knowledge of cellular function, but would also be relevant to the understanding and prevention of cancer.

Public health relevance
Project Narrative These studies will lead to a better understanding of gene regulation, and will therefore provide new insights into the molecular basis and potential treatment of human diseases, such as many forms of cancer, that involve defects in the proper control of gene expression.